Metabolic Profiling in Pediatric Fusion Positive Sarcoma

Abstract Fusion positive sarcoma (FPS) occurs in 1,100 new patients under 18-­years annually in the United States. Advances in understanding the molecular phenotypes of FPS in children have occurred but anticipation that these advances would lead to significant changes in patient care have not been realized. Failure of modern therapies in high-­risk children demands another system of exploration beyond molecular and genome studies, to further an understanding of potentially clinically targetable pathways that would allow categorization of patients, elucidation of treatment response and personalization of therapy. Sophisticated biomarkers evaluating response to therapy in FPS in children have not been successfully developed to allow treatment related decisions. While multifactorial this is in part because of limited sensitivity and specificity of analytes, absence of tumor specimens in patients for whom radiation is delivered to achieve local tumor control and significant time between initiation of therapy and subsequent surgery to resect tumors. An understanding of the metabolic reprogramming in FPS, the overall study objective, holds the promise to overcome some of these limitations. Specifically, it is known that most cancer cells, including FPS, are dependent on increased glucose uptake to provide energy and macromolecular precursors for cell survival and growth. It is also known that cancer related metabolic vulnerabilities are different in culture and in-­vivo. This suggests that in-­vivo studies are a critical element to a comprehensive examination of the metabolic signatures of FPS. UT Southwestern is one of a very few centers worldwide, where the delivery of 13C, a stable heavy isotope of carbon, has been optimized to study metabolic flux in living tumors in children. 13C is easily identifiable from 12C by experimental methods, 12C being the predominant isotope of carbon in nature. Consequently, this allows sophisticated and dynamic examination of the utilization of glucose in metabolically active pathways in cancer cells when tumor specimens are studied from patients who receive concomitant 13C infusion. This is a non-­toxic compound in humans and already the delivery has been developed and ideal dose identified, for children treated at UT Southwestern and Children’s Medical Center Dallas. In aim 1 of this proposal we will examine the metabolic signatures of FPS in children diagnosed and treated over 2-­years at UT Southwestern and Children’s Medical Center Dallas. In aim 2 we will study in parallel pre-­clinical model systems of FPS. These latter systems will include mouse-­models of patient derived tumors, known as patient derived xenografts, wherein we will be able to study metabolic signatures under the effect of commonly used therapies and as tumors evolve over time. Such parallel and complimentary studies will provide the first-­ever comprehensive evaluation of a critically important and biologically relevant cellular pathway in FPS in children and offers the potential to address several limitations in designing effective and personalized treatments for patients for whom current therapies continue to fail.

Public health relevance
Project narrative An urgent need is evident to improve treatment for patients with high- risk features of fusion positive sarcoma, 80% of who will die of disease with current approaches. In order for novel therapies to advance outcomes for children with such disease, we must develop sophisticated tools that will interrogate the effectiveness of treatment within a period of time that allows personalized cancer- directed treatment decisions and that will provide clinically relevant information to avoid prolonged use of ineffective and harmful drugs. Our proposal to interrogate the metabolic reprogramming of fusion positive sarcoma in children by studying tumors harvested from children undergoing treatment, offers the promise of developing a comprehensive and mechanistic understanding of a critically important biological pathway that could deliver the fundamental understanding for such a sophisticated tool.